COLLABORATIVE INVESTIGATION OF DUCHENNE MUSCULAR DYSTROPHY

Serum myoglobulin and creatinine kinase to relatively mild exercise (e.g. walking, day trips) are measured in patients with Duchenne Dystrophy. Excessive responses would raise the possibility of a detrimental effect of exercise in such patients.